Strategies to attenuate the indirect alloimmune response in encapsulated pancreatic islet transplantation

Project Summary
Type 1 diabetes (T1D) is an autoimmune condition that destroys the insulin-producing beta cells within the
pancreatic islets of Langerhans. Although the treatment for T1D is aided with new technology like continuous
glucose monitoring and automated insulin pumps, exogenous insulin administration is the core management
strategy and T1D remains a life-changing and lifelong diagnosis. T1D can be cured by beta cell replacement
through pancreatic islet transplantation, however the need for chronic systemic immunosuppression greatly limits
the applicability of this procedure. Encapsulation of islets within selectively permeable hydrogels prior to
transplantation may eliminate the need for chronic immunosuppression by blocking direct recipient cell and
antibody contact with allogeneic islets. The Tomei lab has developed a unique encapsulation method, “conformal
coating,” that addresses several considerations of traditional encapsulation methods. Altogether, islet
encapsulation has been shown in animal models of T1D to be capable of restoring blood glucose regulation,
however recipient innate and adaptive immune cells including macrophages and T cells still initiate a local
inflammatory and pericapsular response and limit the long-term efficacy of encapsulated islet transplantation.
Given the selective permeability of the hydrogel layer, soluble alloantigens shed by the transplanted islets are
likely triggering an indirect allorecognition pathway, where recipient professional antigen-presenting cells
scavenge and present alloantigens shed by transplanted islets to alloreactive T cells while simultaneously
providing co-stimulatory signal activation. The overall goal of my project is to capitalize on this mechanism by
blocking the co-stimulatory pathways required for T cell activation. I hypothesize that combining encapsulated
islet transplantation with (1) localized and targeted nanoparticle delivery of biologic co-stimulatory blockers
(cytotoxic T lymphocyte antigen 4 immunoglobulin) or (2) co-transplantation with immunomodulatory non-
professional antigen presenting cells (that present antigen but do not provide adequate co-stimulation) will induce
deletion/anergy of alloreactive T cells and promote tolerance to transplanted islets, thereby improving and
prolonging their efficacy in restoring physiologic metabolic control.

Public health relevance
Project Narrative Type 1 diabetes (T1D) occurs when a loss of immune tolerance to insulin-producing beta cells of the pancreas leads to their destruction and blood glucose dysregulation. T1D can be cured with beta cell replacement through pancreatic islet transplantation, but the need for chronic systemic immunosuppression limits the applicability of this procedure. Islet transplantation without the need for chronic systemic immunosuppression can be achieved by encapsulation, where transplanted islets are coated in biocompatible gels that act as a barrier to recipient immune responses. Unfortunately, an indirect immune response still occurs. This proposed project seeks to combine islet encapsulation with two tolerance-inducing therapies that block this indirect immune response, thereby improving the efficacy of encapsulated islet transplantation and its potential for translation to the clinic.